Core A: PREVENT Program Administrative Core

The overall objective of the PREVENT Program is to advance into clinical trials a candidate microbicide gel containing griffithsin (GRFT) that is designed to prevent rectal transmission of HIV-1. The primary responsibility of the Administrative Core (Core A) is to monitor, direct, and coordinate activities of the three research projects and three scientific cores to ensure that this objective is achieved efficiently, as quickly as possible, and in compliance with regulatory and sponsor requirements. The overarching goal of Core A is to provide scientific support to the PREVENT program's projects and cores to enable progression into the PREVENT clinical trial. Specific Aim 1 is to ensure effective PREVENT Program leadership through coordinated efforts of a Steering Committee (SC). Aim 2 is to provide administrative support for the effective functioning of the entire GRFT PREVENT program. Aim 3 is to provide centralized fiscal management of projects and cores, and Aim 4 is to provide an internal structure for both internal and external review of scientific progress.

Public health relevance
In the absence of a preventative vaccine, microbicides offer an alternative to condoms as a feasible method for prevention of HIV-1 sexual transmission. This Core manages the key administrative and fiscal tasks to bring to the clinic a novel candidate microbicide gel containing the potent anti-HIV01 protein griffithsin.